CORD BLOOD DIAGNOSIS OF COAGULOPATHIES IN HIGH-RISK NEWBORNS

Coagulopathies occur frequently in the sick newborn but are difficult to diagnose because of insensitivities in our current screening tests. This study will measure specific fibrinogen/fibrin fragments to develop a more specific and sensitive test of disseminated intravascular coagulation (DIC) and to discern the role of Thrombin act. or plas. in high risk newborns.